Comprehensive noninvasive assessment of liver histopathology in nonalcoholic fatty liver disease (NAFLD) via magnetic resonance imaging, cytometry and elastography (MR-ICE)

PROJECT SUMMARY / ABSTRACT
The growing prevalence of nonalcoholic fatty liver disease (NAFLD) creates an imperative to reliably
distinguish between patients with simple steatosis and those with nonalcoholic steatohepatitis (NASH).
However, hepatic inflammation and cellular injury diagnoses often require invasive liver biopsies for
histopathologic staging. There is an urgent need for safe and reliable noninvasive imaging methods for
diagnosing NASH and longitudinal assessing hepatic inflammation and hepatocellular injury to monitor
treatment efficacy. The presence of and severity of steatosis and fiborosis are now well addressed with
chemical shift imaging and magnetic resonance elastography (MRE). Our current cycle of research has
confirmed that MRE-assessed loss modulus is a very promising biomarker for inflammation. In this renewal
application, we propose to continue validation of this biomarker for inflammation and to add noninvasive
assessment of cell injury (ballooning) by introducing a novel MR cytometry modification into the MRE protocol.
The overall goal of this work is to develop and validate multiparametric MR-ICE imaging technologies for fully
assessing disease states during NAFLD evolution, especially inflammation and hepatocellular injury.
• In Aim 1, we will develop the MR-ICE imaging protocol. Fat fraction will be evaluated with a 6-point Dixon
method. A dual-frequency, self-navigating, and hybrid radial-Cartesian 3D vector hepatic MRE technique will
be optimized for characterizing multiple mechanical properties of viscoelasticity and nonlinearity. MRC
sequence and reconstruction will be developed with gradient waveforms and diffusion signal fitting that are
specifically designed for hepatocyte cytometry, with or without simultaneous MRE acquisition.
• In Aim 2, we will perform longitudinal application of the MR-ICE in an in vivo rat model (N=96, diet-induced
NASH). Technical integrity and diagnostic performance will be assessed by comparing multiple in vivo
imaging biomarkers (fat fraction, hepatocyte size, viscoelasticity, nonlinearity) with ex vivo tissue composition
(water and fat contents), dynamic mechanical analysis (DMA) testing and histologic features (steatosis,
inflammation, ballooning, fibrosis), respectively. Statistical models will be trained to diagnose NASH.
• Prior to pilot clinical evaluation, we will aseess the repeatability of MR-ICE biomarkers in 5 controls and 5
clinical patients using a test-retest strategy. Finally, a pilot clinical evaluation in 10 controls and 40 patients
with biopsy-proven NAFLD/NASH will be performed to provide preliminary evidence of the diagnostic
performance of the MR-ICE protocol for staging NAFLD/NASH.
Emerging therapeutic interventions may require life-long treatment, creating the need for more precise non-
invasive methods for identifying those patients who need such interventions. The development of MR-ICE will
make it possible for us and other investigators to advance the precise noninvasive assessment of NASH.

Public health relevance
PROJECT NARRATIVE This research will develop and validate advanced multiparametric imaging technology which combines magnetic resonance imaging, cytometry and elastography (MR-ICE) to substantially advance noninvasive characterization of the spectrum histopathologic changes in patients with nonalcoholic fatty liver disease. Success of the proposed research will provide critically needed noninvasive technology for identifying patients who have a high risk of developing advanced disease in the nonalcoholic steatohepatitis spectrum, allowing early therapeutic intervention.